Unraveling the Role of The Fibrinolytic-Inflammatory Axis in Severe Trauma Adverse Outcomes: From Acute Organ Dysfunction to Chronic Disability

Severe trauma remains a leading cause of mortality and long-term disability worldwide. Patients who survive the
initial injury face a continuum of complications, from early-phase multi-organ dysfunction syndrome (MODS) to
late-phase post-injury syndrome (PIS). Despite extensive research, a critical knowledge gap remains in
understanding how specific innate immune cells drive these adverse outcomes. This proposal aims to elucidate
the dynamic interplay between the fibrinolytic system and inflammatory response, specifically neutrophil
activation in early injury response, followed by sustained macrophage-driven inflammation in late-phase
complications. Our central hypothesis posits that the spectrum of adverse outcomes stems from sequential
immune cell responses to fibrinolytic dysfunction, centered on the management of the 'damage matrisome.' We
propose a three-phase progression: 1) initial hyperfibrinolysis triggers neutrophil activation and DNAnet
formation, 2) neutrophil-mediated fortification of the damage matrisome creates a fibrinolysis-resistant matrix
that while initially protective, leads to organ inflammation and a hypofibrinolytic state within tissues, and 3)
persistent hypofibrinolysis combined with chronic macrophage activation drives failure of tissue repair,
degeneration and pain (PIS). To test this hypothesis, we will employ a clinically relevant murine model of severe
trauma complemented by comprehensive flow cytometry-based immune cell phenotyping and tissue-specific
transcriptomic analysis. Aim 1 will determine if early hyperfibrinolysis drives neutrophil activation and MODS by
modulating fibrinolysis and assessing its impact on neutrophil phenotype and organ inflammation. Aim 2 will
investigate whether activated neutrophils drive hypofibrinolysis both systemically and within tissues by
manipulating neutrophil responses in both severe and non-severe injury models. Aim 3 will evaluate if
modulating either fibrinolysis, chronic inflammation, or both can mitigate PIS. Important to the clinical relevance
of this work, measures of PIS will include tissue fibrosis/calcification, musculoskeletal inflammation and
degeneration, pain, and musculoskeletal function- all changes observed in severely injured patients. This
research has the potential to revolutionize our understanding of trauma pathophysiology by defining how specific
immune cell populations drive adverse outcomes. By elucidating these mechanisms, we aim to develop targeted,
phase-specific interventions that address both immediate life-threatening complications and prevent long-term
disabilities, ultimately improving outcomes for millions of trauma survivors worldwide.

Public health relevance
Narrative: This research investigates how severe trauma triggers an abnormal breakdown of blood clots, leading to widespread inflammation that can cause multiple organs to fail in the short term and chronic pain and tissue degeneration in the long term. By understanding how specific immune cells respond to and perpetuate this process, we aim to develop new treatments that can be used to prevent these complications. This work could transform how we care for severely injured patients by offering targeted therapies that both save lives in the immediate aftermath of trauma and prevent long-term disability, ultimately helping millions of trauma survivors return to their normal lives.